The impact of ITPR3 mutations on immunity

Project Summary
The inositol trisphosphate receptors (ITPR1, ITPR2, ITPR3) are present in the endoplasmic
reticulum, forming homo- or hetero- tetrameric complexes to control calcium release. Upon
binding to the second messenger, inositol 1,4,5 trisphosphate (IP3), the ITPR controlled release
of calcium controls differentiation, proliferation, and death processes for every cell type in the
body. We identified the same single allelic mutation in the Inositol Tris Phosphate Receptor Type
3 (ITPR3) in two unrelated children. The missense mutation creates a p.Arg2524Cys amino acid
substitution within the calcium channel. These children have immunodeficiency, Charcot-Marie
Tooth disease and partial to complete anhidrosis. While autosomal recessive ITPR3 mutations
cause one form of CMT syndrome, immune system problems and sweating defects are not
normally seen. In fact, most single allelic mutations in ITPR3 are benign due to compensatory
functions by ITPR1 and ITPR2. To understand the basis for the more widespread clinical
presentation our two patients with the single allelic p.R2524C variant, as well as an expanding
number being reported elsewhere, we genocopied the mutation in mice. Our preliminary findings
suggest this Itpr3 p.R2524C variant forms a cell-type specific dominant negative. In the current
proposal, we will determine the impact of this Itpr3 mutation on cell signaling in the immune,
neuronal, and eccrine systems. A characterization of the T and B cells of the adaptative immune
system will be done with a combination of functional assays and signaling studies. Additionally, a
characterization of the Schwann cells of the peripheral nervous system and eccrine cells will be
undertaken. The studies will be complemented with knockdown approaches using shRNA
technologies to determine if functionality can be restored by selectively targeting Itpr3.

Public health relevance
Project Narrative Two infants were identified with an immune deficiency, growth delay, Marie-Charcot Tooth disease and a diminished ability to sweat. DNA sequencing uncovered a mutation in a gene called the inositol triphosphate receptor type 3. A mouse model was developed to understand how this mutation affects the immune, nervous, and secretory systems, with the goal of developing therapies to improve the clinical problems for people with these type of gene mutations.